The Role of Cell-Type Specific Expression of GLT1 at Excitatory Synapses

DESCRIPTION (provided by applicant): The precise regulation by glutamate transporters of glutamate concentrations in and around excitatory synapses is critical for the normal function of excitatory synapses. During cerebral ischemic injury, the third leading cause of death of adults in the United States, extracellular glutamate concentration rises, leading to excitotoxicity caused by excess activation of glutamate receptors. The long-term goal of this research is to understand how glutamate transporters regulate synaptic and perisynaptic glutamate concentrations normally, and how ischemia disrupts glutamate homeostasis to produce excitotoxicity. Although glutamate transporters are well known to be expressed in astrocytes, the identity of the glutamate transporter expressed in the presynaptic terminal of excitatory synapses was unknown, representing a major gap in our knowledge and understanding of excitatory synapses. We discovered that GLT1, previously thought to be exclusively expressed in astrocytes in the mature brain, is expressed in axon terminals in the hippocampus. A major hypothesis of this proposal is that GLT1 is the major glutamate transporter expressed in excitatory terminals throughout the forebrain. The function of GLT1 expressed in axon terminals as opposed to GLT1 expressed in astrocytes is unclear. We hypothesize that expression of GLT1 in neurons is important for the normal function of excitatory synapses, by preventing spillover onto perisynaptic glutamate receptors as well as cross-talk between excitatory synapses. We further hypothesize that the release of glutamate from excitatory terminals is important in the pathogenesis of excitotoxic injury in ischemia. We have generated a mutant mouse in which a critical exon in the GLT1 gene has been flanked with loxP sites, allowing the use of Cre-loxP recombination technology to produce cell-type specific knockouts. In this project we will compare the effects of deletion of GLT1 in astrocytes or in neurons, on glutamate homeostasis and synaptic function under normal conditions and in models of excitotoxic injury. The specific aims are to: 1) Perform phenotypical, morphological, and physiological analysis of mouse lines in which GLT1 is deleted in astrocytes or neurons. 2) Characterize the role of GLT1 expressed in different cell types in the pathogenesis of ischemic injury. 3) Determine whether GLT1 is expressed in excitatory terminals in regions outside the hippocampus. The expression of GLT1 in excitatory terminals has important implications for our understanding of the physiology of excitatory synaptic transmission, synaptic plasticity, and ischemic injury. Using mouse lines that will be produced for this project, we hope to gain important insights into the role of neuronal expression of GLT1 into the normal and abnormal regulation of glutamate at the excitatory synapse.

Public health relevance
PUBLIC HEALTH RELEVANCE: The long-term goal of this research is to understand how glutamate transporters normally regulate glutamate concentrations at and around the excitatory synapse, and how ischemia disrupts this regulation to produce excitotoxicity-death of neurons caused by excess release of glutamate and activation of glutamate receptors. We discovered that the glutamate transporter GLT1 is expressed in excitatory axon terminals, but the function of glutamate transporters in excitatory terminals, as opposed to astrocytes, is unclear. In this project we make mouse lines in which GLT1 expression is deleted in neurons or in astrocytes to compare the effects of expression of GLT1 in these different locations on glutamate homeostasis and synaptic function under normal conditions and in models of excitotoxic injury. The long-term goal of this research is to understand how glutamate transporters normally regulate glutamate concentrations at and around the excitatory synapse, and how ischemia disrupts this regulation to produce excitotoxicity-death of neurons caused by excess release of glutamate and activation of glutamate receptors. We discovered that the glutamate transporter GLT1 is expressed in excitatory axon terminals, but the function of glutamate transporters in excitatory terminals, as opposed to astrocytes, is unclear. In this project we make mouse lines in which GLT1 expression is deleted in neurons or in astrocytes to compare the effects of expression of GLT1 in these different locations on glutamate homeostasis and synaptic function under normal conditions and in models of excitotoxic injury. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The precise regulation by glutamate transporters of glutamate concentrations in and around excitatory synapses is critical for the normal function of excitatory synapses. During cerebral ischemic injury, the third leading cause of death of adults in the United States, extracellular glutamate concentration rises, leading to excitotoxicity caused by excess activation of glutamate receptors. The long-term goal of this research is to understand how glutamate transporters regulate synaptic and perisynaptic glutamate concentrations normally, and how ischemia disrupts glutamate homeostasis to produce excitotoxicity. Although glutamate transporters are well-known to be expressed in astrocytes, the identity of the glutamate transporter expressed in the presynaptic terminal of excitatory synapses was unknown, representing a major gap in our knowledge and understanding of excitatory synapses. We discovered that GLT1, previously thought to be exclusively expressed in astrocytes in the mature brain, is expressed in excitatory axon terminals in the hippocampus. A major hypothesis of this proposal is that GLT1 is the major glutamate transporter expressed in excitatory terminals throughout the forebrain. The function of GLT1 expressed in axon terminals as opposed to GLT1 expressed in astrocytes is unclear. We hypothesize that expression of GLT1 in neurons is important for the normal function of excitatory synapses, by preventing spillover onto perisynaptic glutamate receptors as well as cross-talk between excitatory synapses. We further hypothesize that the release of glutamate from excitatory terminals is important in the pathogenesis of excitoxic injury in ischemia. Previously, the tools to perform critical experiments to test these hypotheses were not been available. We have generated a mutant mouse in which a critical exon in the GLT1 gene has been flanked with loxP sites, allowing the use of Cre-loxP recombination technology to produce cell-type specific knockouts. In this project we will use mouse lines with 4 different genotypes-wildtype, null expression of GLT1, GLT1 expression deleted in astrocytes, or GLT1 expression deleted in neurons-to determine the specific roles of the expression of GLT1 in astrocytes and in neurons on glutamate homeostasis and synaptic function under normal conditions and in models of excitotoxic injury. The expression of GLT1 in both astrocytes and in neurons is likely to be important, with expression in each cell type responsible for different functions, and the knockout of GLT1 expression in each cell-type likely to produce distinct phenotypes. The specific aims are to: 1) Perform phenotypical and morphological analysis of mouse lines expressing GLT1 exclusively in astrocytes or neurons. It has been assumed that expression of GLT1 in astrocytes is sufficient to account for all the essential functions of GLT1. Our published work has demonstrated expression of GLT1 in excitatory terminals in the hippocampus, and preliminary results reveal GLT1 in excitatory terminals in the striatum as well. We hypothesize that mice in which GLT1 expression is deleted in neurons will have defects in excitatory synaptic transmission, specifically, compromised performance on behavioral tests of learning and memory, increased vulnerability to seizure, aberrant long-term potentiation (LTP) and abnormal activation of metabotropic receptors. We have already generated a conditional knockout mouse, from which mouse lines will be produced to test this hypothesis. 2) Characterize the role of GLT1 expressed in different cell types in the pathogenesis of excitoxic injury in the adult brain. During ischemic injury, the concentration gradients of the transported ions fall and the glutamate transporters reverse their operation leading to release of toxic quantities of glutamate. Excitatory terminals contain very high concentrations of glutamate, and are therefore expected to play an important role in the pathogenesis of excitotoxicity due to reversal of GLT1 transport. The hypothesis is that mice in which GLT1 expression is deleted in neurons will be protected against ischemic injury. 3) Determine whether GLT1 is expressed in excitatory terminals in regions outside the hippocampus. Previously published work by others and from our own lab has demonstrated GLT1 mRNA in neurons throughout the cerebrum, but GLT1 protein has not been detected in excitatory terminals outside the hippocampus. This is a critical gap in our knowledge. The hypothesis is that GLT1 expression in excitatory terminals will be a widespread phenomenon in the cerebrum. In addition, our previous study of GLT1 expression in the hippocampus used diaminobenzidine/peroxidase detection, best suited for cellular localization but not for subcellular localization that is critical in achieving an understanding of the function of GLT1 at synapses. We further hypothesize that GLT1 is located in the synaptic cleft, that is, in a location to have a maximal impact on synaptic glutamate transients. To investigate these questions, we will use electron microscopic immunocytochemistry (EM-ICC). In preliminary experiments, we have found GLT1 is expressed in excitatory terminals outside of the hippocampus, in the striatum, and also that GLT1 is expressed in the plasma membrane in the synaptic cleft of excitatory synapses. Glutamate transport plays a critical role in the physiology of excitatory synaptic transmission, synaptic plasticity, and excitotoxic injury. The impact of the proposed research will be to challenge and change our view of how glutamate concentrations at the synapse are regulated in health and disease.